Intravenous VSV virotherapy in lymphoma

The overarching goal of this grant is to develop an optimal viro-immunotherapy approach for the treatment of relapsed
refractory (R/R) T cell lymphoma (TCL). VSV-IFNβ-NIS is an oncolytic Vesicular Stomatitis Virus (VSV) engineered to
selectively infect and kill tumor cells, while sparing normal cells. In the recently completed first-in-human dose
escalation study utilizing a single intravenous (IV) infusion of VSV-IFNβ-NIS in patients with R/R multiple myeloma (MM)
and TCL, we reported that the virus can be safely administered up to the highest dose level tested (1.7e11 TCID50) with
no dose limiting toxicities. The most exciting and significant clinical activity was seen in patients with TCL who received
one dose of 1.7e11 TCID50 VSV-IFNβ-NIS as a single agent, with 5 clinical responses (2 CR and 3 PR) in 10 heavily
pretreated patients with multi-focal TCL. Pharmacokinetics (PK) and pharmacodynamics (PD) correlative analyses
suggest that responses are due to a combination of direct oncolytic tumor destruction and immune-mediated tumor
control. However, not all patients responded, and several patients had mixed tumor responses only. We recently
showed in preclinical models that addition of anti-CTLA-4 (αCTLA4) and anti-PD1 (αPD1) antibodies given prior to VSV-
IFNβ-NIS resulted in complete remission of established tumors in 100% of mice. Thus, the goal of this grant is to improve
the 50% response rate and durability of response (DOR) in patients with TCL by maximizing the potency of VSV-IFNβ-
NIS using immune checkpoint blockade (ICB) to amplify the antitumor activity of virotherapy-boosted tumor-reactive
CTL. In parallel, we seek to identify biomarkers and immune correlates differentiating responders from non-responders
in TCL through analysis of tumor biopsies and blood.
We thus have the following specific aims:
Specific Aim 1. Determine the safety, PK/PD and efficacy of one IV of VSV-IFNβ-NIS in combination with immune
checkpoint antibodies for patients with R/R TCL. Hypothesis: Immune activation with αCTLA4 and αPD1 antibodies
followed by destruction of TCL with VSV virotherapy will maximize the boosting of antitumor cytotoxic T cells to bring
about long-term tumor control and remission.
Specific Aim 2. Determine the baseline tumor gene expression profile (antiviral and immune) and tumor mutation
burden (TMB) and evaluate their impact on clinical response. Hypothesis: A VSV permissive gene signature and high
TMB are positive contributing factors to the depth and durability of response.
Specific Aim 3. Determine the impact of VSV-IFNβ-NIS treatment with αCTLA4 and αPD1 immune boosting on the
kinetics, magnitude and specificity of antitumor CTL and Treg immune responses. Hypothesis: Timely addition of the
immune modulators with VSV virotherapy will result in enhanced frequency and duration of antigen reactive T cells.
Upon completion of this study, we will achieve a deeper understanding of parameters that drive responses in viro-
immunotherapy, and potentially derive a new treatment option worthy of further clinical development in patients with
R/R TCL. Results from this study will also provide the foundation for building more effective dosing for other cancer
indications.

Public health relevance
Narrative We recently showed that a single intravenous dose of an oncolytic Vesicular Stomatitis Virus encoding human interferon beta and the sodium iodide symporter imaging gene (VSV-IFNβ-NIS) is able induce shrinkage of multiple tumors in 5 patients (2 complete responses, 3 partial responses) with aggressive, treatment refractory TCL out of 10 that were treated. In this grant, we are seeking funding to increase this efficacy signal by combining virotherapy with immunotherapy to further improve therapeutic outcome and durability of clinical responses in patients with relapsed refractory TCL, as well as looking for factors that drive response in the patients.